Targeting Health Disparities through Housing Redevelopment: A Natural Experiment of Housing Quality, Stability, and Economic Integration

Contact PD/PI: COLEY, REBEKAH Levine
PROJECT ABSTRACT
By exploring stress exposure, neighborhood perceptions and experiences, perceptions of access and
inequality, and mental and physical health among Black residents in an urban public housing community, this
project provides a unique opportunity to contribute to a growing body of research that examines intraracial
differences in mental and physical health outcomes among Black Americans. Results will further understanding
of the complexities of Black health and well- being, enduring racial health disparities, and the social, political,
and environmental contexts that drive health disparities within urban settings. This study will further racial
health disparities research through the following specific aims: Aim 1: Trace neighborhood demographic,
political, and social shifts from 1980-present to ground an examination of variations in environmental inequality,
perceptions of inequality, and resource utilization for Black residents. Aim 2: Expand the qualitative substudy
sample size and add a focus on how Black residents define and construct their subjective neighborhood
boundaries (physical and symbolic), experiences, and sociohistorical understandings of their neighborhood,
including variation across gender, age, and ethnicity. Aim 3: Use mixed methods research to examine stress
exposure, stress experience/appraisal, coping resources, and links to mental and physical health outcomes
among Black residents, including variation across gender, age, and ethnicity.
Project Abstract Page 6

Public health relevance
Contact PD/PI: COLEY, REBEKAH Levine PROJECT NARRATIVE The proposed study aims to better understand stress exposure, neighborhood perceptions and experiences, and perceptions of access and inequality among Black Americans. Findings from this study contribute to a growing body of research that examines intraracial differences in mental and physical health outcomes among Black Americans in order to further understand the complexities of Black health and well-being, enduring racial health disparities, and the social, political, and environmental contexts that drive health disparities within urban settings. Using a mixed methods design anchored in a sociohistorical, intersectional framework, the findings from the proposed study will also provide a nuanced, layered exploration of social determinants of health at the intersection of race, ethnicity, gender, and age. Project Narrative Page 7